Improving Black sarcoidosis patients’ care with a collaboratively developed, patient centered program

Project Summary/Abstract
The purpose of this K23 Career Development Award is to develop Logan Harper MD, MS as an
independent investigator with a focus in health disparity research in sarcoidosis. This funding
will allow pursuit of his research plans to develop a patient centered intervention to address root
causes of health disparities seen in Black sarcoidosis patients. The structured mentoring plan
includes hands-on experience administering and analyzing a large prospective patient
questionnaire study, and using community-based research techniques to develop and pilot test
an intervention collaboratively developed with Black sarcoidosis patients to address root causes
of health disparities. This experience will be supplemented with structured coursework in
statistical and community-based research techniques. This work will provide accelerated
development of an independent career path. Dr. Harper will benefit from a multidisciplinary
team of mentors, including Dr. Daniel Culver, a world authority on sarcoidosis, Dr. J Daryl
Thornton, an expert in health disparities and community-based participatory research, and Dr.
Raed Dweik, a proven mentor of early career researchers.
Under the supervision of Drs. Culver and Thornton, Dr. Harper has quantitatively established
the association of social factors with healthcare disparities, and qualitatively interviewed patients
to understand patient important mediators of health disparities in sarcoidosis. This work
supports the feasibility of the present research proposal, which aims to 1) quantify the
association of patient reported barriers to care with patient important sarcoidosis outcomes
through prospectively collected surveys, 2) utilize community-based research to collaboratively
develop an intervention to address mediators of poor sarcoidosis outcomes in Black sarcoidosis
patients, and 3) pilot test the intervention developed in aim 2 with local Black sarcoidosis
patients to determine acceptability, uptake, and identify appropriate outcomes and sample size
for a future randomized controlled trial. Completion of the proposed project will provide the most
comprehensive characterization of patient reported mediators of sarcoidosis outcomes to date.
Additionally, this work will lay the ground work for a future multi-centered cluster randomized
controlled trial of a novel, patient designed intervention to reduce healthcare disparities in Black
sarcoidosis patients. The training in this structured mentoring plan is designed to provide Dr.
Harper the framework to seek further research funding near the completion of this award, a step
towards his goal of becoming an independent clinician scientist.

Public health relevance
Project Narrative Sarcoidosis is a multisystem inflammatory disease that is known to cause disproportionate morbidity to Black patients, and no interventions have been developed or tested to address this known disparity. We will utilize validated patient reported outcome measures to characterize the prevalence of patient reported barriers to care, their association with outcomes, and the impact of race on these associations. We will use community- based research to develop and pilot an intervention to address the most prevalent and harmful barriers to care in Black sarcoidosis patients, in keeping with the NIMHD's research interests of epidemiological research on population intersectionality and community-based intervention adaptation research.